Evaluation of the Philadelphia Smart Street Lighting Initiative

Project Summary
A controlled trial evaluation of the Philly Streetlight Improvement Project
Firearm violence, especially within urban neighborhoods of concentrated disadvantage,
is a persistent public health problem in the US. There is a growing body of experimental
evidence that place-based interventions that improve the built environment can help curb gun
violence. Experimental and quasi-experimental evaluations show that street lighting, a common
municipal investment, is effective at reducing violence8-10 Yet, the effectiveness of a permanent
citywide improvement in street lighting has never been scientifically tested. Understanding
whether improvements in street lighting can have an impact on gun violence at scale is of
critical value to policymakers who must decide how to allocate scarce resources among many
different crime control strategies. Building on our prior experimental and quasi-experimental
studies, we propose to conduct the first citywide quasi-experimental study of the installation of
energy-efficient “smart” street lighting and its potential impact on shootings, gun assault,
robberies with firearms, and weapons offenses. This will be the first multi-year study of the
benefits upgrading street lighting on gun violence across multiple neighborhoods and can inform
other cities that are looking for place-based investments that can help curb the epidemic levels
of gun violence impacting neighborhoods of concentrated disadvantage in US cities.
In the first phase of the project we will study changes in gun violence outcomes in the 12
months before and after the installation of new street lights on 300 blocks compared to 900
blocks that have yet to have lights installed and have comparable pre-existing monthly levels of
gun violence. In the second phase of the project we will estimate the citywide impact by
estimating a difference-in-differences regression for approximately 40,000 blocks in the city that
have new street lights installed between years 2023-2025. Key covariates will also be
accounted in the difference-in-differences regression models as well as adjustments for multiple
testing. Critically, our research will also involve qualitative assessments of the implementation of
street lights and a partnership with the Urban Affairs Coalition to assess whether street lighting
upgrades help to facilitate equity and feelings of safety to economically disadvantaged
neighborhoods.

Public health relevance
Project Narrative To the best of our knowledge, there have been no prior controlled trials of the effects of a citywide installation of energy-efficient street lighting on gun violence outcomes. Leveraging the staggered rollout of an ambitious public infrastructure project which will upgrade of all 130,000 street lights in Philadelphia, we will study the at-scale effects on investments in street lighting on gun violence outcomes. The proposed project’s findings will contribute to the local and national effort to understand ways to improve the built environment of communities and reduce the burden of gun violence.